NEW METHODOLOGY FOR ORGANIC SYNTHESIS

This project involves the development of a number of new reactions and concepts for Organic Synthesis. The potential for our bisannulation strategy in the convergent synthesis of polycyclic molecules will be examined. New functionalized pentadienyl anions for intramolecular Diels-Alder reactions will be investigated. The synthesis of 25-hydroxy vitamin D will be carried out. Several routes to a taxane molecule suitably functionalized for further elaboration will be studied. The intramolecular Diels-Alder reaction of benzofurans will be investigated as a potential route to morphine.